CT Conformance with the Manufactured Food Regulatory Program Standards (MFRPS)

Project Summary/Abstract for Connecticut's Application for RFA‐FD‐17‐005: Conformance with the Manufactured Food Regulatory Program Standards The intended outcome of this application is to advance Connecticut toward a nationally integrated food safety system. This will be accomplished by assisting the State's manufactured food regulatory program to maintain achievements and conformance with the FDA's Manufactured Food Regulatory Program Standards (MFRPS). The MFRPS are a set of ten standards, the conformance of which is intended to ensure that State's program develops, and maintains best practices for a high‐quality regulatory program. As a by‐product, the program standards are also intended to enhance food safety by establishing a uniform basis for measuring and improving the performance of Connecticut's manufactured food regulatory program. Conformance with these program standards will help the State program better direct regulatory activities at reducing hazards in firms that manufacture, process, pack, or hold foods. Connecticut will also pursue a special project related to emergency response directed at food that will further enhance the capacity of the State manufactured food regulatory program to protect public health and safeguard the food supply in the State.

Public health relevance
Project Narrative for Connecticut's Application for Grant Funds under RFA‐FD‐17‐005: Conformance with the Manufactured Food Regulatory Program Standards (MFRPS) The goal of this grant is to support the Connecticut MFRPS programs is to achieve and sustain conformance with the MFRPS (2016 or most recent edition). This is recognized as a critical element to creating a national, fully integrated food safety system. Once recognized as accomplishing that goal as it relates to the State's manufactured food regulatory program, the State Program will continue to contribute to the continuous improvement of the MFRPS through attendance at an annual face‐to‐face meeting, active participation in committees, and other initiatives such as webinars, special assignments in supporting the MFRPS. The following objectives with further strengthen and expand the State's goal as outlined above. Specifically the MFRPS Program will: 1. Research and develop strategies for achieving and sustaining conformance with the MFRPS to share on a national basis. 2. Will provide FDA the foundation for pursuing regulatory action based upon the findings of State manufactured food regulatory programs conducted in accordance with the Standards and associated best practices. 3. Ensure food safety staff successfully complete training courses required for conformance with the MFRPS and maintaining the food contract in satisfactory condition. 4. The program will work to ensure that a laboratory awarded a current FDA ISO Laboratory Accreditation Cooperative Agreement, the regulatory program grantee will provide for the collection of samples to support laboratory capacity development and product surveillance. 5. Demonstrate the ability to perform any enforcement or other follow‐up activities based on sample or inspection results. 6. Develop sampling plans collaboratively with the laboratory to support program objectives.